Molecular Mechanisms of IL-1R-TLR-Mediated Signaling

[unreadable] DESCRIPTION (provided by applicant): The goal of proposal is to understand the molecular mechanisms by which IL-1R-TLR signaling modulates the development and pathogenesis of atherosclerosis. Genetic and biochemical studies by us and others revealed that IL-1R-TLRs induce TAK1(TGF[unreadable]-activated kinase 1)- and MEKK3(MAP kinase kinase kinase 3)-dependent pathways, involving cascades of kinases organized by multiple adapter molecules into parallel and sequential signaling complexes, leading to activation of the transcription factor NFκB. IL-1R-TLRs also mediate mRNA stabilization of cytokines and chemokines, which is essential for effective inflammatory response. We have recently shown that IL-1R-TLR-mediated TAK1-dependent NFκB activation is coupled with the mRNA stabilization pathway to induce the robust production of cytokines and chemokines. On the other hand, the IL- 1-R-TLR-mediated MEKK3-dependent pathway is uncoupled from mRNA stabilization pathway and is only able to induce expression of genes that are not regulated by mRNA stability (including inhibitory molecules A20 and IkBa), exerting an overall inhibitory effect on inflammatory gene expression. Based on these findings, we hypothesize that IL-1R-TLRs trigger inflammatory response by coupling TAK1-dependent NFκB activation with mRNA stabilization pathway to induce robust production of cytokines and chemokines. The IL-1R-TLR- mediated MEKK3-dependent NFκB activation pathway is inhibitory to the overall inflammatory response by uncoupling gene transcription from mRNA stabilization and by producing inhibitory signaling molecules that turn down production of cytokines and chemokines. To test this hypothesis, we propose to elucidate the molecular mechanisms that coordinately regulate IL-1R-TLR-induced TAK1-dependent NFκB activation and mRNA stabilization pathways(Aim 1); delineate molecular mechanisms for IL-1R-TLR-induced MEKK3- dependent NFκB activation and its role in uncoupling gene transcription from mRNA stabilization(Aim 2); and investigate the patho-physiological functions of IL-1R-TLR-induced TAK1- versus MEKK3-dependent NFκB activation and mRNA stability signaling cascades in the development of atherosclerosis(Aim 3). PUBLIC HEALTH RELEVANCE: Our studies will elucidate a new mechanism that will help to explain how inflammation is developed and controlled in the development of vascular diseases such as atherosclerosis. The long-term objective is to develop more effective anti-inflammatory and anti-atherogenic small molecule drugs. [unreadable] [unreadable] [unreadable]